Effects of a housing policy experiment on youth behavioral problems

DESCRIPTION (provided by applicant): Adverse neighborhood contexts predict poor mental health and externalizing behavior among adolescents, and the vast racial inequalities in neighborhood environment may play an important role in creating and maintaining racial disparities in health. However, since most research has been observational rather than experimental, it is potentially biased. Neighborhood-health research typically models point-in-time exposures of neighborhoods, in lieu of understanding neighborhood exposure trajectories, and insufficient attention has been paid to the specific contexts navigated by minority, impoverished, adolescents. Our study proposes a secondary analysis of data from a social experiment of voluntary neighborhood relocation using Section 8 Housing Vouchers in 5 cities (the Moving to Opportunity, MTO, Study), to test how and why random assignment of an offer to move to a low-poverty neighborhood unexpectedly adversely affected behavioral problems for boys over a 4-7 year period, and to inform the program's opposite gender effects on mental health. We will complement the existing data with additional neighborhood-level data collection to enrich the dataset. MTO is the only available large- scale study that has randomly assigned individuals to receive different neighborhood contexts, to support strong causal inferences of how neighborhoods shape mental health. Yet prior MTO analyses have not integrated theoretical understanding of adolescent development to motivate empirical analyses. Nor have prior analyses probed why neighborhood context may increase behavioral problems of boys, whether certain subgroups are more likely to be affected than others by neighborhood relocation, or whether there are important developmentally-sensitive periods when exposure to neighborhood deprivation may be especially influential on youth mental health. Our project proposes 3 aims: Aim 1: To test whether effects of moving to a low-poverty neighborhood on behavioral problems for boys are mediated by neighborhood characteristics, family context, or substance use. Aim 2: To examine, separately among boys and girls, whether the effect of moving to a low-poverty neighborhood on behavioral problems is modified by baseline health status, family/adolescent vulnerability, or program site. Aim 3: To compare the importance of alternative timing or sequencing patterns of exposure to neighborhood poverty on behavioral problems among boys. The project will leverage an interdisciplinary team of investigators, including fields of social epidemiology, psychiatric epidemiology, developmental psychology, demography, public policy, statistics, medicine. This project will capitalize on an experimental design, will innovatively apply causal methods to understand mediation, and will model time-varying neighborhood exposures, which will inform relevant early life course developmental timing of neighborhood exposure periods for adolescent well-being. Because of the rigorous experimental design, this project can provide strong policy-relevant evidence on the mechanisms by which social policies like Section 8 housing vouchers may influence population health and mental health.

Public health relevance
PUBLIC HEALTH RELEVANCE: Neighborhood context may be an important cause of health disparities, especially taking into account risks which accumulate early in life. The results of this project, leveraging a social experiment of housing relocation, have the potential to inform the literature on why neighborhood context is a cause of behavioral problems among adolescents, including probing more specificity on when and for how long living in low-poverty neighborhoods may be most influential for affecting adolescent mental health. This knowledge will inform the next generation of interventions and policies to ensure that adolescents are not harmed by rental assistance policies; results from the experimental design will inform causal pathways and potential intervention points by which to reduce the population burden of mental health and subsequent health disparities. Neighborhood context may be an important cause of health disparities, especially taking into account risks which accumulate early in life. The results of this project, leveraging a social experiment of housing relocation, have the potential to inform the literature on why neighborhood context is a cause of behavioral problems among adolescents, including probing more specificity on when and for how long living in low-poverty neighborhoods may be most influential for affecting adolescent mental health. This knowledge will inform the next generation of interventions and policies to ensure that adolescents are not harmed by rental assistance policies; results from the experimental design will inform causal pathways and potential intervention points by which to reduce the population burden of mental health and subsequent health disparities. __SpecificAimsTextDelimiter__ 2. Specific Aims Given the high residential segregation in the US1, neighborhood inequalities may play an important role in creating and maintaining racial disparities in health2,3. Adverse neighborhood contexts predict poor mental health and behavioral problems among adolescents4-22. Yet most neighborhood-health research is not experimental,11,23 and therefore potentially biased, providing an unreliable foundation for policy translation.23-25 Moving To Opportunity (MTO) is the only large-scale study that randomly assigned volunteer low-income families to exposure to different neighborhood contexts (using Section 8 housing vouchers). Girls and women who relocated to low-poverty neighborhoods in the MTO treatment group experienced strong beneficial effects on mental health, compared with controls remaining in public housing. But boys in the treatment group exhibited unexpectedly worse mental health than controls.4,5,26 It is especially crucial to understand these adverse effects because MTO incorporated major components of federal housing policy for poor urban populations27. Contexts (and reactions to context) navigated by low-income minority adolescents may be highly gender-specific (e.g. area-based social norms or masculinity shaped by male mentors).11,28 But neighborhoods research rarely examines gender explicitly. When it was launched, MTO was touted as one of the most promising policies to disrupt the toxic effects of neighborhood poverty for minority children and families. But health researchers have had limited access to these data, compromising the scientific payoff of the $70+ million investment26 for understanding how neighborhoods influence health and development. So it is not yet understood why MTO affected adolescent mental health,29 or whether other subgroups were affected by the program. We have obtained the MTO data, and propose new analyses, using novel applications of state-of- the-art causal methods. We will assess mediators, modifiers, and developmental specificity of the effects of randomly-assigned neighborhood context on adolescent behavioral problems over 4-7 years. We will compile additional neighborhood data, to inform MTO gender differences. While prior analyses of MTO focused on estimating average treatment effects and have not integrated theories of youth development to motivate empirical analyses,27,30,31 we will estimate the effects of time-varying neighborhood exposures, allowing for developmental-period-specific causal effects (using structural nested models), and leveraging the rigorous experimental design32,33 to inform causes of youth behavior. We focus on 3 research questions and aims: Why did boys who moved to low-poverty neighborhoods in the MTO program exhibit worse mental health? Aim 1. To test whether effects of moving to a low-poverty neighborhood on boys' behavioral problems in the MTO study are mediated by neighborhood characteristics, family social context, or substance use. H 1.1. The MTO treatment changed neighborhood quality on dimensions relevant for behavior problems, including gender-specific stressors and adolescent-specific contexts. H1.2-1.4. The MTO behavior- problem treatment effects are partially mediated by neighborhood quality; by changes in family context (e.g. mother's or sibling's mental health, parenting style); and by substance use. H1.5. For variables that mediate adverse behavioral problem-treatment effects for boys, treatment did not influence such variables for girls. Were some subgroups especially likely to be harmed by, or to benefit from, the MTO treatment of moving to a low-poverty neighborhood? Aim 2: To examine, separately among boys and girls, if the MTO intervention effect on adolescent behavioral problems was worse for children with pre-existing developmental vulnerability, from families with lower socioeconomic status, or in certain cities. H 2.1- 2.2. Experimental condition teens from families with a disabled family member, with history of childhood health or developmental problems, or with lower baseline maternal education or family income, experienced more adverse behavioral problems effects, compared to families with less vulnerability. H2.3: There was heterogeneity in treatment effects on behavioral problems by program site. Are there developmental differences in the "dose" and/or timing of neighborhood poverty in the MTO study that are relevant for mental health of boys? Aim 3. To compare the importance of alterna- tive timing or sequencing patterns of exposures to neighborhood poverty on behavioral problems among boys, using cutting-edge causal methods that model time-varying exposures. H 3.1: Longer duration of residence in a low poverty neighborhood is associated with more behavioral problems among boys (cumulative effect). H 3.2: Current neighborhood-level poverty more strongly affects boys' behavioral problems than neighborhood-level poverty at prior times (pathway effect). H 3.3: Boys' behavioral problems are influenced by neighborhood-level poverty to which they are exposed during several specific adolescent developmental periods (sensitive periods). H 3.4: The true causal effect of low-poverty neighborhood residence will be harmful for boys' behavioral problems, and of larger magnitude when estimated with structural nested models that model time-varying exposures, compared to traditional "static" methods. This innovative project integrates rigorous state-of-the-art causal methods with understanding of adolescent development, applied to a uniquely powerful and underused dataset. Our results will vastly enrich our understanding of neighborhood context as a cause of behavior problems, for effective policy translation.